Societal assumptions regarding typical personhood and their effects on reasoning development

Project Summary
This project will uncover the developmental processes by which children acquire the belief that White males
represent the default person—a pattern rooted in the ideologies of androcentrism (centering the experiences of
men) and ethnocentrism (centering the experiences of White people) prevalent in the United States. Despite
national rises in racial and gender diversity, White men remain vastly overrepresented across a host of
domains within the U.S., from media, to politics, to clinical research. Such overrepresentation poses severe
costs to the rest of society—women of all races, men of color, and gender-nonconforming individuals—
particularly within the domain of health, where clinical trials have historically prioritized the experiences,
perspectives, and health outcomes of White men. To address this issue, we must understand when and how
the tendency to view White males as default people develops across childhood, as well as the environmental
factors that underlie this phenomenon. Specifically, we need to know (a) the developmental trajectory by which
children’s default representations of people begin to favor Whiteness and maleness over other identities, (b)
the specific domains across which children do (and do not) activate a White male default to guide social
reasoning, and (c) the sociocultural and ecological factors that can prevent the development of these beliefs.
Young children actively construct knowledge to make sense of their social environments. As part of this
process, children absorb complex streams of information from the sources around them, including parents,
peers, and broader societal institutions (e.g., media). Thus, the beliefs children acquire tend to reflect the
dominant ideologies embedded in their specific cultural contexts: within the United States, androcentrism and
ethnocentrism represent two such ideologies. The proposed research will uncover the ways in which children’s
representations of the broad category people reflect both androcentrism and ethnocentrism. To this end, Aim 1
will reveal the developmental trajectory of children’s beliefs that White males—more so than Black males,
White females, or Black females—best exemplify a person. Aim 2 will clarify the scope of children’s beliefs
about who best exemplifies a person by testing the consistency of this belief across domains. Finally, Aim 3
will uncover the features of children’s sociocultural and ecological environments that underlie beliefs about who
best exemplifies a person, providing insight into the mechanisms underlying the patterns documented in Aims
1 and 2. By administering these studies via an innovative platform for remote, unmoderated research, we have
the unique opportunity to reach families from all across the United States. The diversity afforded by this
platform allows us to capture a holistic picture of the phenomenon in question and the mechanisms underlying
it, broadening both the empirical rigor and real-world impacts of our findings.

Public health relevance
Project Narrative White men remain vastly overrepresented across a host of domains within the United States, a pattern that poses severe health costs to the rest of society, particularly as clinical trials continue to prioritize the experiences, perspectives, and health outcomes of White men. This overrepresentation reflects the tendency to view White males as the default person—a pattern rooted in the ideologies of androcentrism (centering the experiences of men) and ethnocentrism (centering the experiences of White people) prevalent in the United States. To address this issue, this project will reveal when and how the tendency to view White males as default people develops across childhood, as well as the environmental factors that underlie this phenomenon.